AIDS and Aging Research Platform (AARP)

As living with HIV has become a chronic health condition globally, it is widely accepted that other health concerns will affect the quality of life of people living with HIV and increase their need to access wider health services to reduce morbidity and mortality. In addition to an older population Aging with HIV who require additional care and support for co-morbidities, infants Aging with HIV, some of which are already adolescents or young adults, also require age-appropriate care and support. It is thus more timely than ever to compile and share good practice examples of integrated and/or differentiated health service delivery to maximise access to inclusive and quality care. To this end, the IAS would like to include a supplement to the current R33 NIH grant on Aging with HIV to convene a session at IAS 2021 on the topic and to publish a JIAS supplement for launch in 2022, with enhanced dissemination of the content to broaden the reach to additional stakeholders to maximise impact. Drawing on the convening reach of the IAS, the intention would be to connect the latest scientific evidence and leading community perspectives from around the world, including low and middle income countries as well as more developed nations.

Public health relevance
Relevance to public health The “HIV and Aging” Spotlight session at IAS 2021 and Supplement in the Journal of the International AIDS Society (JIAS) aims to foster improved collaboration and information-sharing regarding HIV and aging populations and hopes to guide the efforts of diverse researchers to improve service provision for people aging with HIV in different environments and contexts. The meeting will focus particularly on the needs of individuals aging with HIV in low and middle income countries. The meeting will take an approach that is person centered, inclusive and focuses on quality to advance thought leadership about health outcomes and quality of live for people living with, vulnerable to and aging with HIV.